TEMPERATURE DEPENDENCE OF MAGNETIZATION TRANSFER

A technique was investigated that improves the contrast of magnetic resonance images by applying a low-power radio-frequency irradiation 10 kHz from the main water proton resonance frequency to excite macromolecular hydrogens. This contrast is different from Tl and T2 contrast of MR images, and is called magnetization transfer contrast (MTC) . Diffusion may be involved in this process, so the temperature dependence of both parameters was measured.